Targeting of Krüppel-like Factor 5 (KLF5) in Pancreatic Ductal Adenocarcinoma

PROJECT SUMMARY
Pancreatic ductal adenocarcinoma (PDAC) is an extremely deadly tumor type with one-year and five-year
survival rates of less than 20% and 10% respectively. This project seeks to explore the potential for Krüppel-like
factor 5 (KLF5) to be a novel therapeutic target in PDAC. The proposed research leverages three key
discoveries. First, high-throughput genetic screening has revealed that PDAC human cancer cells are selectively
sensitive to KLF5 inactivation. Second, KLF5 expression is low in normal pancreas tissue, but KLF5 is
upregulated during pancreatitis and supports the proto-oncogenic function of Kras in this context. Third, mouse
genetic studies indicate that normal intestinal stem-cell self-renewal continues in the absence of Klf5. These data
together suggest KLF5 has a wide therapeutic index in PDAC. However, KLF5 is a difficult target for classical
drug discovery approaches, largely due to our limited understanding of protein-protein interactions which support
KLF5 function. This project will address two major gaps in our understanding of KLF5 in PDAC. It will evaluate
whether targeting KLF5 interactions disrupts KLF5 function, and it will explore how KLF5 contributes to proto-
oncogenesis of PDAC precursor cells.
An integrated high-throughput reporter screen and mass spectrometry analysis has illustrated that several KLF5
coactivators also bind KLF5. These coactivators will be deeply investigated to reveal the mechanisms of their
interactions with KLF5. This investigation will highlight whether KLF5-coactivator interactions are critical both for
KLF5 transcriptional activity and for PDAC cell fitness (Aim 1). The overall goal of this aim is to understand if
these interactions can be exploited to acutely target KLF5 activity in PDAC. This will inform the potential for the
advancement of KLF5 as a targeted therapy.
In addition, pancreatitis promotes an aberrant proto-oncogenic epigenetic landscape, and also leads to Klf5
upregulation. Using a transgenic mouse model, the function of Klf5 in normal and inflamed pancreatic tissue will
be interrogated. Specifically, this investigation will determine if Klf5 supports the aberrant epigenic profile induced
by pancreatitis (Aim 2). The overall goal of this aim will be to determine if Klf5 has an active role in shaping the
genome of PDAC progenitor cells. This might explain why PDAC is selectively sensitive to KLF5 deletion, while
KLF5 is entirely dispensable in normal pancreatic homeostasis.
The required skills and knowledge to carry out these two aims will be supported by sponsor Dr. Chris Vakoc and
co-sponsor Dr. David Tuveson, in addition to the Cold Spring Harbor Laboratory School of Biological Sciences.
The mentorship and environment at Cold Spring Harbor Laboratory will provide all of the necessary resources
for a tailored training program to effectively develop the applicant into an independent experimentalist, analyst,
and communicator of gene regulation biology and cancer research.

Public health relevance
PROJECT NARRATIVE Over 90% of pancreatic cancer patients die within 5 years of diagnosis because we currently lack effective treatments. We recently discovered a specific protein, Krüppel-like factor 5 (KLF5), is selectively essential for pancreatic cancer cell growth, and may therefore be a compelling target. In this project, we will combine innovative models and approaches to determine how KLF5 functions in pancreatic cancer and to evaluate if targeting KLF5 represents a promising therapeutic opportunity.